Addressing Trauma from Interpersonal Violence through a Web-based Peer Navigation-Social Support Intervention to Improve ART Adherence among Women

PROJECT SUMMARY
Disparities in HIV diagnoses and care continuum outcomes are paramount among racial and ethnic minority
women in the United States. These disparities are further impacted by the complex interaction of syndemic
conditions (e.g., interpersonal violence, adverse mental health, substance use). Simultaneously, structural
factors (e.g., intersectional stigma, medical mistrust, discrimination) engender health inequities among racial and
ethnic populations and have been qualitative linked to poor engagement in HIV care. Racism perpetuates HIV
stigma and medical mistrust; less commonly studied, structural racism, refers to the interplay between systems,
social forces, institutions, and processes, which may also impact engagement in HIV care. The proposed
administrative supplement seeks to fill this gap and aims to understand potential racial and ethnic differences in
the role of structural racism and other socio-structural barriers (e.g., intersectional stigma, medical mistrust,
discrimination) in the utilization and retention of HIV care and other ancillary support services among women
living with HIV in California. The proposed administrative supplement will leverage data from participants enrolled
in the Women SHINE study (Addressing Trauma from Interpersonal Violence through a Web-based Peer
Navigation-Social Support Intervention to Improve ART Adherence among Women; #R01MH125785; PI:
Stockman), a two-arm randomized control trial among non-ART adherent cisgender WLH with a history of
adulthood interpersonal violence residing in California. Quantitatively, we will leverage baseline survey data from
the parent study (n=200) that includes measures to capture structural factors (intersectional stigma, medical
mistrust discrimination) to conduct a series of logistic regression models that test for potential racial and ethnic
group differences (i.e., White, Black, Latina, and Other [Indigenous, Asian American, and Native Hawaiian and
Pacific Islander]) in the association between socio-structural factors and past year and retention in HIV care and
other ancillary support services (i.e., domestic violence agencies, mental health, substance use outpatient
clinics) (Aim 1). Qualitatively, we will generate data through in-depth interviews with WLH (n=40, 10 per racial
and ethnic group) randomized to the control arm to explore the role of structural racism and other socio-structural
factors on utilization and retention in HIV care and other ancillary support services (Aim 2). Finally, we will
triangulate the quantitative and qualitative data while conducting member checking through four focus groups by
racial and ethnic group (n=4-6 women each) (Aim 3). Collectively, this study will expand the current limited
knowledge base on racial and ethnic differences in socio-structural factors that influence care engagement
among WLH and inform innovative ways in which researchers can intervene upon these socio-structural factors
to improve HIV care engagement among WLH, particularly Black and Latina women, who are disproportionately
affected by HIV.

Public health relevance
PROJECT NARRATIVE Women living with HIV, particularly those who are racial and ethnic minority, experience multiple syndemic conditions (e.g., interpersonal violence, adverse mental health, substance use) and socio-structural factors (e.g., intersectional stigma, medical mistrust, discrimination), which may operate as barriers to engagement in HIV care. A key socio-structural factor, structural racism, fuels HIV stigma and medical mistrust within racial and ethnic communities. We proposed to leverage quantitative baseline survey data from participants enrolled in the Women SHINE Study (Grant #R01MH125785; PI: Stockman) to conduct a concurrent mixed methods study examining racial and ethnic differences in structural racism and other socio-structural factors on utilization and retention in HIV care and other ancillary support services among women residing in California.